EFFECTS OF EXERCISE ON RESETTING THE ENDOGENOUS CIRCADIAN PACEMAKER

The purpose of this study is to determine the effect of exercise on the daily clock by monitoring your core body temperature under special conditions.